2/2 Partnership for Native American Cancer Prevention

PROJECT SUMMARY/ABSTRCT: OVERALL
The Partnership for Native American Cancer Prevention (NACP) is uniquely positioned to address cancer
health inequities in Native American communities. Cancer is the second leading cause of death for Native
Americans over the age of 45 years. Despite improvements in cancer screening techniques and major
developments in cancer treatment in past decades, tribal communities have not benefited equally from these
advances. Further, the NIH recognizes that Native Americans have the lowest representation of all
underrepresented groups in the biomedical research workforce, which contributes to the overall cancer health
inequities for this population. NACP began in 2002 as a partnership between Northern Arizona University
(NAU), as the institution serving underserved health disparity populations and underrepresented students, and
the University of Arizona Cancer Center (UACC), as the Comprehensive Cancer Center. The overarching
goals of NACP are to increase NAU's cancer research and UACC's cancer health disparities capacities by
honoring existing and establishing new Native American community partnerships. To meet these goals, the
following aims are proposed: Aim 1. Conduct Pilot Research Projects and Full Research Projects, which
address Native American cancer disparities and reflect community concerns; Aim 2. Recruit and support
Native American faculty focused on cancer research; Aim 3. Create a new shared resource called “Guiding
U54 Investigator Development to Sustainability (GUIDeS)“ with the goal to facilitate the transition of NACP-
affiliated, Early Stage Investigators/Junior Investigators to research independence; Aim 4. Expand and
implement cancer disparities research education with a focus on Native American students across NAU/UA
undergraduate and graduate programs; Aim 5. Integrate community engagement principles into all NACP
activities, facilitating dissemination of the Partnership's research findings and the National Outreach Network's
initiatives to Native American communities. To achieve these Aims, two Full and one Pilot project are
proposed; two have Native American co-leaders. One of the Full projects and the Pilot project combine basic
science and community engaged research to address gastric and cervical cancer; death rates for these
cancers are higher in Native American populations. We propose Administrative, Planning and Evaluation,
Research Education, Outreach and GUIDeS Cores to support the research projects and integrate activities
across the Partnership. NAU and UACC commit institutional funds to support new projects and Native
American investigators. New priorities in this proposal are community engaged research that will impact cancer
screening rates, recruitment and mentoring of Native American early stage investigators, grant writing activities
to sustain Native American-focused cancer disparities research and initiatives, and joint research education
curricula to develop a stronger Native American biomedical workforce. By the end of the proposed funding
period, NACP will move Native Americans in Arizona closer to cancer health equity.

Public health relevance
NARRATIVE The Partnership for Native American Cancer Prevention (NACP) is well-situated to impact cancer health disparities for Native Americans in the Southwest. The goals of the NACP are to further increase: the cancer research at Northern Arizona University, the cancer health disparities research at the University of Arizona Cancer Center, cancer research education capacity for Native American researchers, and the number of Native American students and investigators in the cancer disparities workforce. We strive to make NACP the nationally-recognized leader in cancer disparities research, education, and outreach activities focused on the needs and concerns of tribal communities.